MOTHERS AND BABIES--MOOD AND HEALTH

This is a substudy of the Mothers and Babies: Mood and Health Project. The parent project will eventually result in a randomized control trial to test whether new episodes of major depression can be prevented in young pregnant women. The current substudy will: (1) examine the relationship between salivary cortisol and depression concurrently and prospectively (i.e., do high levels in pregnancy predict postpartum depression?), 2) administer a structural diagnostic interview to obtain psychiatric diagnoses in a sample of 150 Spanish and English-speaking pregnant women aged 15-30 recruited at SFGH's Women's Clinic.